Identifying Ecological Drivers of Dysbiosis in the Female Reproductive Tract

PROJECT SUMMARY/ABSTRACT
Dysbiosis in the female reproductive tract (FRT) occurs when unknown ecological factors in the vaginal
microenvironment drive the expansion of suboptimal bacterial communities that contribute to disease. Our
understanding of the host and microbial-derived factors that contribute to FRT dysbiosis is limited, and as such
we lack effective strategies for restoring vaginal homeostasis in at-risk women.
Aerobic vaginitis occurs when enteric opportunists such as Escherichia coli subvert the dominance of
glycogen fermenting commensals to expand in the FRT, causing severe inflammation and tissue atrophy. The
host-derived factors that drive the bloom of facultative anaerobes in the FRT during aerobic vaginitis are unclear,
but risk factors include hormonal changes during pregnancy, menopause, etc. We and others have observed
that mice in specific reproductive phases (estrus and metestrus) are highly susceptible to vaginal E. coli
colonization suggesting hormonal-driven changes in the FRT may influence pathogen susceptibility in mice. Our
preliminary findings show that estrogen alters vaginal epithelial cell metabolism, reduces epithelial hypoxia, and
drives a respiration-dependent bloom of E. coli that induces subsequent inflammation in the FRT. From these
findings, I hypothesize that hormone-induced metabolic reprogramming of the host epithelium towards aerobic
glycolysis increases luminal oxygenation of the vaginal tract, allowing E. coli to outcompete fermenting
anaerobes and induce an inflammatory response that perpetuates chronic aerobic vaginitis. Here, I propose to
use genetically tractable uropathogenic E. coli (UPEC) in combination with specialized animal and tissue culture
models to identify the specific host and bacterial metabolic pathways that contribute to aerobic vaginitis. In AIM1,
we will determine how host cell metabolism controls vaginal community composition during homeostasis. In
AIM2, we will use UPEC to identify host and microbial metabolic pathways that facilitate the bloom of facultative
anaerobes during vaginal dysbiosis. In AIM3, we will explore how UPEC ecosystem engineering facilitates
persistent colonization of the female reproductive tract during aerobic vaginitis. Together, these studies will
provide much-needed insight into the factors that influence vaginal health and disease and reveal new
therapeutic targets for supporting women’s reproductive health.
The support of this K99/R00 Pathway to Independence award will facilitate the training necessary to
achieve these aims, including training in advanced microbiome techniques, specialized conventional and
gnotobiotic mouse models, and further career development. With the combined support of an outstanding
mentorship team and the world-class technical and intellectual resources available at UC Davis, the proposed
scientific aims and training objectives will form the foundation for an independent research program aimed at
uncovering the ecological drivers of dysbiosis in the FRT.

Public health relevance
PROJECT NARRATIVE The vaginal microbiome is an essential barrier to disease that is compromised in 1/3 of all women. Our understanding of the ecological drivers that control vaginal microbiota composition is limited, and as such we lack effective treatments to restore homeostasis in women suffering from dysbiosis. Here, we propose to elucidate the host and bacterial factors that contribute to vaginal dysbiosis to reveal new therapeutic targets that bolster a protective vaginal microbiota community and strengthen this important, yet understudied aspect of women’s health.